Spatiotemporal transcriptomics at the maternal-fetal interface in COVID placenta

COVID-19, caused by severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), has emerged as the
greatest threat to global health and significantly impact pregnant women worldwide. COVID-19 infection during
pregnancy is associated with substantial risk of increases in maternal morbidity and mortality and neonatal
complications, compared with their non-infected pregnant counterparts. However, vertical transmission of the
virus is uncommon, which suggest that innate immune system must function at the maternal-fetal interface to
shield the developing fetus from infection. Despite fast-tracked intensive research on many aspects of SARS-
CoV-2, the impact of the viral infection in the placenta and the placental defense mechanism(s) are poorly
explored. Placenta is the structural and immunological barrier of pathogen transmission. To explore the innate
antiviral defense mechanism(s), in our preliminary study we specifically determined expression of interferon
pathway-related molecules in placental tissues. Strikingly, we found distinct patterns of stimulator of interferon
genes (STING), interferon regulator factor 3 (IRF3), and Type I IFN (such as IFNb) expression at the maternal-
fetal interface of the placentas from women infected with COVID-19. STING is a sensor for viral infection.
STING-IRF3 pathway signaling regulates Type I IFN production, and Type I IFNs are potent antiviral cytokines.
We also noticed that Toll-like receptor 7 (TLR7) is upregulated in both syncytiotrophoblasts (
STs) and
extravillous trophoblasts (EVTs) in placentas from patients with COVID-19 compared to those are not. TLR7,
located on the X chromosome, is a sensor for single strand RNA (ssRNA) viruses. These findings are intriguing
and indicate that an innate antiviral immune system is activated at the maternal-fetal interface in patients with
COVID-19 during pregnancy. The objective of the study is to identify spatiotemporal transcriptomic signatures
and networks of the innate antiviral immune system at the maternal-fetal interface. We will test the hypothesis
an effective and robust innate antiviral immune system is activated at the maternal-fetal interface to prevent
viral transmission and shield the fetus from infection, which will be tested in two specific aims.
Aim 1 will
identify spatiotemporal innate immunity gene profiles and networks in villous tissue that respond to maternal
SARS-CoV-2 infection. Aim 2 will identify spatiotemporal innate immunity gene profiles and networks in fetal
membrane and decidual tissue that respond to maternal SARS-CoV-2 infection. A state-of-the-art novel
technique of 10x Genomics Visium Gene Expression assay in placental formalin-fixed paraffin embedded
(FFPE) tissues combined with RNA-seq will be employed
. Placentas from women with active COVID infection,
recovered from COVID infection, and received COVID vaccination, etc. will be studied. This novel ideal
approach will allow us to map the whole transcriptome with morphological context in placental FFPE tissue and
discover the cellular and molecular profiles and networks in different cell types and gene activity at the
maternal-fetal interface without disruption of the tissue integrity. Results of the study will provide novel insights
into how
SARS-CoV-2 infection
impacts the innate immune system at the mater-fetal interface, and how the
innate immune system at the maternal-fetal interface responds to COVID vaccination during pregnancy, which
may help to identify new strategies to prevent COVID-19 infection and reduce maternal and fetal complications
in women with COVID-19 infection in the future.

Public health relevance
Project Narrative In this proposed study, we will identify innate/adaptive antiviral immune signatures and profiles in different cell types (including syncytiotrophoblasts (STs), cytotrophoblasts (CTs), extravillous trophoblasts (EVTs), villous stromal cells, Hofbauer cells, amniotic epithelial cells, and maternal decidual cells, etc.) at the maternal-fetal interface in placental tissue. Placental tissue from women infected with COVID-19, recovered from COVID-19 infection, and received COVID vaccination, during pregnancy, etc. will be studied. Novel technique of 10x Genomics Visium Gene Expression Assay combined with RNA- seq will be utilized. Results obtained will uncover gene network activities to show how different cells at the maternal-fetal interface behave in response to systemic COVID infection during pregnancy; if improper activation of the innate/adaptive antiviral immune system at the maternal-fetal interface is associated with adverse maternal and fetal outcomes, and what are the cellular and molecular consequences at the maternal-fetal interface following COVID vaccination, etc. Results obtained from the study may also provide evidence to institute new strategies in clinical management to prevent COVID-19 infection in the future.